Anatomical and functional organization of inter-areal feedback circuits in the visual cortex, and their impact on neuronal responses

SUMMARY
The goals and specific aims of the present Administrative Supplement application are unchanged
with respect to the parent R01 award. Here we request additional funds for unanticipated
expenses within the original scope of the project. In the original application we proposed to
investigate the anatomical and functional organization of V2-to-V1 feedback (FB) circuits arising
from, and terminating in specific cortical layers in macaque monkeys. At the time we submitted
the parent R01 application, we could obtain non-naïve macaque monkeys at a cost of
approximately $2,000 per animal. Due to a country-wide shortage of macaque monkeys, we can
no longer obtain these non-naïve monkeys, and the current price for a cynomolgus macaque is
$23,500 per animal (including shipping). This requires significant additional costs, which we
cannot cover with the funds awarded. Therefore, with the present Supplement application we
request additional funds to cover the increased costs of the animals, which are necessary to carry
out the proposed studies.

Public health relevance
NARRATIVE Normal brain function depends on the orderly development of circuits in the cerebral cortex and on their intact function. Knowledge of the normal circuitry provides a foundation for understanding the causes of impaired brain function and developing corrective measures. Our studies of the normal circuitry between early visual cortical areas will provide greater insight into the causes and effects of central vision defects when these circuits are damaged by stroke or other neurological or developmental cause. In particular, our studies of feedback circuits between different visual cortical areas will help our understanding of how these pathways mediate the influence of stimulus context on neuronal responsivity, spatial integration, and changes in visual sensitivity associated with top-down attention. Moreover, understanding how these circuits operate in normal vision will provide a foundation for understanding the consequences of their dysfunction in neurological and psychiatric disorders, such as autism, schizophrenia and attention deficits disorders, which have been directly linked to abnormalities in inter-areal connectivity [e.g. Belmonte et al. J. Neurosci. (2004) 24:9228-9231; Lynall et al. J. Neurosci. (2010) 30:9477-9487].